ACT 2 PROJ 2 LONGEVITY FOODS AND OBESITY-ASSOCIATED INSULIN RESISTANCE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Obesity has reached epidemic proportions in the United States and is closely linked to type 2 diabetes and cardiovascular disease (CVD), leading the Surgeon General to issue a call for a national effort not only to identify the causes of obesity, but also to outline effective and culturally appropriate interventions. Efficacies of current therapies for obesity are complicated due to inability to maintain long-term weight loss, while those for type 2 diabetes are prone to drug-drug interactions and various side effects, such as additional weight gain and secondary failure. Interestingly, the occurrence of chronic diseases, such as diabetes and heart disease, among Okinawan Japanese is only one fifth that of Americans. Among the various lifestyle factors are lower calorie intake and high consumption of fruits and vegetables. The long-term goal of this research is to investigate the efficacy of medicinal/functional foods to prevent and/or ameliorate obesity-associated insulin resistance, diabetic dyslipidemia and CVDs, and to identify the underlying mechanisms. This project aims to identify specific molecular targets and delineate the mechanisms involved in ameliorating obesity-associated insulin resistance, using Momordica charantia (bitter melon, BM), an Asian vegetable. The specific aim of the project in year three was to investigate Sirt-PPARgamma-NCoR interactions in adipocytes. We expect to translate the results of the in vitro and in vivo studies to clinical trials among minority populations with obesity and/or type 2 diabetes mellitus. Such studies may have a significant impact on the development of therapeutic regimens that can be incorporated into the daily diet.